Training in Hearing and Communication Neuroscience

Project Summary
In 2009, faculty at the University of Southern California (USC) who study the neuroscience of hearing and
vocal communication established a research training program for pre- and post-doctoral scholars. The Hearing
and Communication Neuroscience (HCN) Training Program brings together a broad spectrum of scientists to
enhance inter-disciplinary communication and offers the advantage of providing research training opportunities
that bridge basic science with translational research and clinical applications. The program serves to reinforce
research and training interactions between scientists who study basic aspects of hearing and vocal
communication in the Dornsife College of Letters, Arts & Sciences; the Keck School of Medicine; and the
Viterbi School of Engineering at USC. The program combines the strengths of an outstanding group of
researchers, the resources of USC graduate programs in Neuroscience, Development / Stem-Cell /
Regenerative Medicine, Psychology, Linguistics, and Biomedical Engineering, as well as the excellence in
clinical otology provided by the Department of Otolaryngology. The rationale of this proposal is to engage pre-
and postdoctoral trainees in a highly interactive and multi-disciplinary training experience—ranging from cell
biology and engineering to cognitive neuroscience and linguistics, but unfettered by conventional departmental
barriers—to actively facilitate their development as independent scientists. We have successfully filled
positions with outstanding pre- and post-doctoral scholars during the first fifteen years of the program.
Predoctoral trainees typically join the program during the second year of their graduate training; the level of
experience of post-doctoral trainees participating in the program varies. All trainees receive multi-disciplinary
training in all aspects of hearing and communication neuroscience, as well as practical skills that prepare them
for careers in independently funded research, education, and industry. Our demonstrated ability to expose
trainees directly to cutting-edge research in basic science as well as ongoing clinicalresearch and applications
is a major strength of the program.

Public health relevance
project narrative information for your application. This section must be no longer than 30 lines of text. Project Narrative This proposal focuses on research and training directly relevant to hearing loss, speech and language disorders, and communication disorders in humans. The training program will prepare a cadre of young scientists to address fundamental questions pertaining to hearing and communication neuroscience. These individuals will not only advance our understanding of biological and behavioral bases of a broad spectrum of auditory-vocal communication disorders but will also generate innovative diagnostic and therapeutic applications.